PSYCHOGENIC ILLNESS IN RESPONSE TO PANDEMIC OR MASS BIOLOGICAL EXPOSURE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. . A randomized, controlled experiment will be conducted with three conditions (total N=200) to demonstrate proof of concept of experimental induction of psychogenic symptoms and effect of health messages on rate of symptom induction